Investigating Ethical Challenges in Emerging Precision Medicine Research with Disability Communities: The Case of Cerebral Palsy

Innovations in precision medicine are rapidly changing scientific understandings of the causes of and
potential treatments for the broad range of health conditions affecting the one-in-four Americans living with
disabilities. Alongside the potential benefits of precision medicine research (PMR) initiatives comes a diversity
of perspectives on the role PMR and precision medicine should play in treating or curing disabling conditions.
However, little is known about the perspectives of disability communities towards emerging PMR into
conditions that have not historically been understood as genetic. Prospectively facilitating values alignment
raises ethical and political challenges. Existing literature on disability inclusion and anti-ableism in PMR
provides insufficient guidance on how to facilitate consensus among the perspectives of researchers, people
with disabilities, their caregivers, and clinicians.
Using emerging PMR on cerebral palsy (PMR-CP) as a case study, the overall objective of this K01 is
to prospectively align the values of precision medicine researchers and diverse disability communities in order
to guide development of diagnostics and treatments that better serve the needs of those with disabilities. The
proposal has three specific aims. AIM 1: Assess the values and priorities of key stakeholders in PMR-CP,
using semi-structured interviews to characterize how they perceive potential benefits and harms of PMR-CP.
Stakeholders will include PMR-CP researchers, adults with CP and primary caregivers of those with CP, and
clinicians caring for CP patients. AIM 2: Using data from Aim 1, create and test briefing materials for guiding
democratic deliberation on PMR-CP. AIM 3: Using the data from Aim 1 and materials developed in Aim 2,
facilitate deliberative democratic sessions with members of the stakeholder groups interviewed to negotiate
consensus on the ethical values that should motivate future PMR-CP, which can serve as a model for other
disabling genetic conditions.
Dr. Mintz will achieve these aims by drawing on his current skills in special education, political theory,
and clinical bioethics, as well as on additional training in human genetics and genomics and empirical
deliberative democracy methodologies. Dr. Mintz’s approach to the project will also be informed by his lived
experience of cerebral palsy. His proposed training and research will take place at the Stanford Center for
Biomedical Ethics. Dr. Mintz is already widely respected in disability bioethics for his scholarly
accomplishments and for breaking down barriers for people with disabilities. Through the support of this award,
Dr. Mintz will build upon his current expertise to become one of the few disability bioethicists who is trained in
genetics and empirical approaches to deliberative democracy. If successful, his research will refine a
methodology for negotiating consensus among precision medicine researchers, members of the CP
community, and clinicians, which can be used as a model for other disabling conditions.

Public health relevance
Project Narrative Precision medicine research has the potential to revolutionize scientific understandings of causes and potential treatments for the broad range of health conditions affecting the one-in-four Americans who live with disabilities. Yet, controversies over precision medicine initiatives focusing on disabling conditions, like the Spectrum 10K study for Autism Spectrum Disorder, illustrate that strategies are needed for prospective values alignment between precision medicine researchers, people with disabilities, and those who care for them. Using emerging precision medicine research on cerebral palsy as a case study, my project refines deliberative democracy methodologies to prospectively inform values alignment promotion among precision medicine researchers, members of disability communities, and clinicians specializing in the care of patients with those disabling conditions.